Pathophysiology of Diabetic Gastroparesis

PROJECT SUMMARY/ABSTRACT
Diabetes mellitus is associated with multiple complications including diabetic gastroparesis. The systemic
effects of diabetes modify all cells in the body but in common with other diabetic complications, gastroparesis
does not develop in all patients. Delayed gastric emptying (GE) in the absence of obstruction defines
gastroparesis and also occurs in some but not all diabetic mice. These observations suggest that together with
genetics, convergence of systemic changes with local factors is necessary to develop delayed GE in diabetes.
We previously have found that delayed GE that is associated with loss of interstitial cells of Cajal (ICC), which
in turn is associated with fewer CD206+ muscularis propria macrophages (MPMs). MPMs play a central role in
modifying the cellular content and biological environment of the GI muscularis propria in health and disease.
The source of gastric MPMs and the mechanisms for activation of injurious molecules in MPMs by diabetes are
not known. The overall hypothesis of this proposal is that the underlying central determinant of delayed
gastric emptying in diabetes is the combination of a programmed activation response evoked in
monocytes and the tissue environment of new monocyte-derived MPMs in the gastric muscularis
propria. This will be tested in three specific aims (SA). SA1 will determine the effect of diabetes on circulating
monocytes that primes them for infiltration and activation in gastric muscularis propria. SA2 will determine the
origin of activated MPMs that populate the gastric muscularis propria following onset of diabetes and SA3 will
determine how newly established and activated MPMs cause cellular injury in the diabetic stomach. The SAs
are supported by extensive preliminary data. 1) We have found that systemic exposure to diabetes modifies
the epigenomic landscape of circulating monocytes so that monocytes are poised to express a restricted
complement of signaling pathways when they enter the tissue and become MPMs; 2) MPMs in the diabetic
stomach are derived from infiltrating monocytes; 3) Diabetes results in the presence of new, distinct, discrete
types of MPMs that are unique to the tissue; 4) Lineage-tagged, long-lived MPMs are not changed by diabetes;
5) Disruption of cellular metabolism in the gastric muscularis propria by diabetes activates monocyte-derived
MPMs in close apposition to ICC to produce injurious cytokines, which cause damage to ICC and disrupted
gastric function. To address the overall hypothesis we have developed techniques to isolate identified MPMs
and monocytes, applied highly sophisticated technology for profiling genes by single cell RNASeq, ATAC-Seq,
and proteins by mass cytometry (CyTOF), and determined changes in the epigenomic landscape in innate
immune cells based on phenotypes identified in single cell studies. The preliminary data and the proposed
experiments position us to identify the key steps that determine the responses to diabetes in innate immune
cells that result in development of delayed GE. The new knowledge gained will be crucial to direct targeting of
the mononuclear phagocyte system for prediction, prevention and treatment of diabetic gastroparesis.

Public health relevance
PROJECT NARRATIVE/ LAY SUMMARY Diabetic gastroparesis is a complication of diabetes that causes the stomach to not empty well and as a result of our previous work we know that increased oxidative stress, loss of interstitial cells of Cajal, and changes to specialized immune cells called macrophages are the most common cellular abnormalities. We now focus on the mechanism by which diabetes changes a blood cell type called a monocyte that enters the stomach and becomes an activated macrophage, which disrupts stomach function by damaging interstitial cells of Cajal. This new understanding will permit us to develop therapies for gastroparesis that target these cells.